Intestinal granuloma formation during Yersinia pseudotuberculosis infection

Project Summary/Abstract
In various infectious and non-infectious contexts, chronic immune stimulation induces the formation of
granulomas: aggregations of recruited immune cells that are thought to encapsulate pathogens and prevent their
dissemination. Despite being a prominent feature of numerous infections, key gaps in our knowledge are
the mechanisms of granuloma formation and the functional role of these structures in controlling
infectious disease. Yersinia are bacterial pathogens that block immune cell function and induce granuloma
formation in lymphoid tissues. Yersinia pseudotuberculosis (Yptb) causes self-limiting gastroenteritis and
lymphadenitis in immunocompetent hosts following fecal-oral transmission. Yptb subverts the immune response
through the injection of Yersinia outer proteins (Yops) into nearby immune cells through a needle-like type III
secretion system, blocking functions such as phagocytosis and pro-inflammatory gene expression. While
granulomas are well-described during Yersinia infection of lymphatic tissue, relatively little is known about early
intestinal infection. In this proposal, we describe, for the first time, a murine model of granuloma formation
in the intestinal mucosa during acute Yptb infection. Importantly, live bacteria are abundant within
granulomas but are largely absent from surrounding non-granuloma intestinal tissue, suggesting that granulomas
play a previously uncharacterized role at the intestinal mucosa, an immunological barrier that bottlenecks
Yersinia dissemination. Interestingly, Yptb lacking Yops does not induce intestinal granuloma formation,
suggesting that these structures form in response to features of bacterial virulence. Further, intestinal
granulomas are highly enriched in neutrophils and inflammatory monocytes. Strikingly, monocyte-deficient Ccr2-
/- mice show defects in restriction of bacterial dissemination, succumbing to acute infection. Similarly, mice
deficient in tumor necrosis factor (TNF) signaling, a cytokine that enhances phagocyte microbicidal function,
exhibit defects in bacterial restriction. I therefore hypothesize that blockade of immune cell function by Yop
effector proteins induces the formation of intestinal granulomas, which protect the host through
bacterial restriction mediated by monocyte-derived TNF. In this proposal, I will investigate the formation and
function of intestinal granulomas from both the bacterial and host sides. First, I will uncover how Yersinia
virulence factors induce intestinal granuloma formation by testing a panel of Yop mutant strains, in addition to
using an injection reporter strain (Aim 1). Second, I will dissect immune cell functions that are necessary for
restriction of Yersinia by intestinal granulomas through complementary mechanistic studies using chimeric
animals and genetic ablation systems (Aim 2). This work will mechanistically define a previously unappreciated
facet of the host immune response to Yersinia infection. Findings from this novel model of intestinal granuloma
formation will provide insight into future work on poorly-studied granulomatous disorders and underscore
potential therapeutic targets for the treatment of chronic disease.

Public health relevance
Project Narrative These studies will define the bacterial and host factors that induce intestinal granuloma formation during Yersinia infection, informing potential immunological therapies to enhance granuloma-mediated control of chronic infections. Importantly, this system provides a novel model to study intestinal granulomas, lending knowledge into difficult-to-model diseases characterized by poorly studied granuloma formation in the intestine, including Crohn’s disease and sarcoidosis. Since granuloma formation is a conserved feature in both infectious and non-infectious contexts, findings from this work could inform future therapeutic, diagnostic, and experimental approaches for numerous chronic diseases.